NEORAL VS SANDIMMUNE IN LIVER TRANSPLANT PATIENTS

The Neoral OLN 354 protocol seeks to compare a new formulation of cyclosporine A (a transplant immunosuppressant) Neoral, to Sandimmune. We propose to utilize CRC to administer Omnipaque and collect and process 3 blood samples for a non-FDA approved assessment of GFR. GFR (glomerular filtration rate) is an accepted measurement of renal function.